Understanding Ras effector switching and roles of Ras>RalGEF>Ral in development

SUMMARY
Ras is the most mutated oncoprotein and functions at the center of an evolutionarily conserved
network of proteins mutated in the RASopathy spectrum of heritable developmental disorders.
Certain facets of Ras biology, like signaling cascades downstream of the Raf and PI3K oncogenic
effectors, are among the best studied and pharmacologically targeted signals in all of biology. Yet
how Ras switches between different effectors and the roles of the oncogenic RalGEF>Ral effector
during development are poorly understood due to paralog redundancy, technical limitations in
more complex systems, and the roadblock of Ral using the exocyst complex as a signaling
intermediary. Research in this laboratory focuses on understanding the composition,
organizational principles, and functions of signal transduction networks in vivo. This proposal will
support a series of projects to answer how Ras switches between effectors in different
developmental contexts, explore unexpected signaling relationships with other characterized
signaling cascades, untangle the apparently paradoxical relationship between Ral and the
exocyst complex in signaling vs. exocytosis, and to identify and understand novel functions of
RalGEF>Ral signaling in development and physiology, about which surprisingly little is known.
The laboratory has developed several crucial technical advances to overcome barriers to
progress in this field. The proposed projects build on the lab’s ability dissect complex webs of
signal transduction using genetic principles, complemented by cell biological and biochemical
approaches. The proposed research is reasonably expected to discover novel principles and
components in signal transduction.

Public health relevance
Inappropriately activated Ras lies at the center of more than a third of all tumors and the RASopathy spectrum of birth defects, yet Ras itself is relatively undruggable, with key partners and the contexts in which they are used poorly understood. This proposal seeks to understand the mechanisms of Ras effector switching and the role served by its neglected partners in diverse biological functions, using the invertebrate experimental animal C. elegans as a simple model to delineate molecular and cellular mechanisms. The long-term goal of this work is to define biomarkers and druggable targets for therapeutic interventions into birth defects and tumors.